Integrated, Multidisciplinary Training in Cardiovascular Research

This T32 Program, titled “Integrated, Multidisciplinary Training In Cardiovascular Research”, is in its 45th
year and is dedicated to the training of cardiovascular scientists with MD and/or PhD degrees. Previously
focused on training in cellular and molecular biology, during the last 5-year renewal we expanded its scope
to include translational and clinical research while strengthening its roots in rigorous fundamental research
and adding new areas of investigation including multi-dimensional ‘omics, molecular imaging, computational
biology, machine learning and artificial intelligence. During the next cycle of this award we will continue to
train the next generation of scientists in scientific inquiry across a broad range of disciplines that enable
transformative discovery in cardiovascular science. The graduates of the Program have been highly
successful in multiple ways, which include publishing in high-profile journals, obtaining extramural funding,
and securing outstanding independent faculty positions. The vast majority of past trainees (88%) continue to
focus on research with academic appointments as faculty or via research and leadership positions in
industry. 47% have been awarded career development grants (K-award or equivalent). We anticipate that
this trend will continue as the current fellows complete their training and submit career development awards.
New faculty were recruited to the award to enable trainees to benefit from dramatic recent advances in
cardiovascular science. The 28 faculty members on the award are recognized leaders, rigorous and ethical
scientists, as well as proven and outstanding mentors. Training is firmly centered on an intensive research
experience under the supervision of skilled primary and secondary mentors, with unique opportunities for
innovation at the interface between fields. In recognition of the increasingly complex scientific landscape our
trainees must navigate, we have substantially strengthened the didactic curriculum of the program, which
now includes new mandatory lectures in scientific methods, biostatistics, rigor and reproducibility, machine
learning and data science. Support is provided for 3 trainees at any given time to obtain masters degrees in
public health, bioinformatics or other fields, and all trainees receive mandatory training in the responsible
conduct of research. The faculty and trainees are closely linked by a tradition of collaboration and a shared
training mission. In addition to a dedicated T32 lecture curriculum, the CVRC/T32 seminar series, cardiology
grand rounds, CVRC retreat, journal club and “Science Social” meetings bring trainees and faculty together
on a regular basis. Trainee progress is closely monitored by the mentors and co-mentors, as well as the
Program Directors. The Program Directors provide regular updates to an External Advisory Committee, and
a concerted effort is made to recruit and retain underrepresented minority candidates. As demonstrated by
the strong track record of this Training Program, graduates are rigorously and systematically prepared to
lead independent research programs at the cutting edge of cardiovascular science.

Public health relevance
Project Narrative: This training grant, which is in its 45th year, provides NIH funds to the Cardiology Division at the Massachusetts General Hospital to train the next generation of scientists in cardiovascular research. Our training program continues to have an excellent track record of training scientists who remain in academia/research and go on to become leaders in their chosen research fields.